Interrogating Mechanisms of Suppressed Tpex Immunotherapy Response in Metastatic Tumor-Draining Lymph Nodes

PROJECT SUMMARY/ABSTRACT
Tumor-reactive CD8 T cells become exhausted and lose their capacity to kill cancer cells in the tumor
microenvironment. Progenitor-exhausted CD8 T cells (Tpex) found primarily in tumor-draining lymph nodes retain
their stem-like properties and respond to immune checkpoint blockade. However, our group’s recent work
suggests that Tpex responses to ICB are disrupted in the metastatic lymph nodes of head and neck cancer
patients. Mass cytometry showed that fewer Tpex are present in metLN; spatial proteomics also revealed that Tpex
were less likely to co-localize with their differentiated, cytotoxic counterparts and more likely to be surrounded
by immunosuppressive CD4 T and dendritic cells (DC). Furthermore, in a retrospective analysis of patients with
recurrent head and neck cancer, we found that those with metLN were less likely to respond to ICB. To
investigate the biology underlying the interruption of Tpex responses to ICB in metLN, we will use the metastatic
4MOSC1 (ICB responsive) and 4MOSC2 (ICB non-responsive) orthotopic mouse models of head and neck
cancer. In our preliminary studies, we have identified immune cell subsets, including endogenous Tpex, in the
tdLN of 4MOSC1 tumors and have established workflows for the isolation and co-culture of T cells and DC from
individual tdLN in vitro. This proposal will use the 4MOSC1/2 mouse model of head and neck cancer to
evaluate mechanisms by which Tpex responses to ICB are disrupted in metLN. Aim 1 will interrogate
whether defects in the S1P/S1PR1 lymphocyte migration axis in metLN affect Tpex responses to ICB. Aim 2 will
evaluate whether activation of Tpex in metLN confers cell-intrinsic defects that affect their capacity to differentiate,
survive, and signal through their T cell receptor. Aim 3 will identify mechanisms by which metastases in tdLN
affect the polarization of CD4 T cells and activation of DC proximal to Tpex. Aims 1 and 2 will use well-established
in vivo and in vitro methods; Aim 3 will use spatial proteomic and transcriptomic tools. These studies will be
the first to mechanistically interrogate how early tumor-reactive CD8 T cell responses are impeded in
metLN. Uncovering this biology has the potential to elucidate novel strategies for potentiating immunotherapy
responses in patients with advanced, metastatic disease in several cancer types. This research project and
fellowship training will be conducted at a top-funded research institution, the University of California,
San Francisco (UCSF), in the laboratory of Dr. Matthew Spitzer with expert mentorship from Dr. Jason
Cyster and Dr. Karin Pelka. Dr. Spitzer is an expert in CD8 T cell and lymph node biology, systems immunology,
and high-dimensional single cell analyses. Dr. Cyster is a world-class scientist who discovered the lymphocyte
trafficking mechanism explored in Aim 1. Dr. Pelka is a cancer immunologist with expertise in the spatial
biological tools to be utilized in Aim 3. Overall, this institution and team provide a rich training environment for
completion of this research and the development of professional skills necessary for a career in academic
research.

Public health relevance
PROJECT NARRATIVE Progenitor-exhausted T cells (Tpex) are the primary subset of tumor-reactive CD8 T cells that respond to immune-checkpoint blockade therapy (ICB) in tumor-draining lymph nodes. The capacity of Tpex to respond to ICB, however, is restricted in the metastatic lymph nodes (metLN) of patients with head and neck squamous cell carcinoma (HNSCC); Tpex are less abundant, less likely to egress out of the lymph node into the blood, and more likely to co-localize with immunosuppressive immune cells. This proposal investigates the mechanisms by which Tpex responses to ICB are restricted in metLN in a clinically relevant mouse model of HNSCC to reveal strategies by which to reinvigorate this critical pool of CD8 T cells in patients with advanced-stage disease.